VOLUNTARY IMMUNOMODULATION IN ADOLESCENTS

To examine whether or not children and adolescents can alter specific immune responses via cyberphysiologic strategies such as relaxation- imagery, self hypnosis, or biofeedback exercises.